Using Implementation Interventions and Peer Recovery Support to Improve Opioid Treatment Outcomes in Community Supervision

PROJECT ABSTRACT
Initiating and/or continuing medications for OUD (MOUDs) in the correctional setting improves health outcomes
among persons with OUD. Despite this evidence, barriers remain to MOUD programming in the correctional
system. Efforts have been made to address barriers preventing systematic implementation of MOUD treatment
programs in correctional settings. Nationwide, there is progress in the availability of technical assistance for
jurisdictions seeking to implement MOUD but barriers continue to exist and critical pragmatic tools are
needed. The main objective of this supplement application is to validate two separate but related tools used to
evaluate MOUD programs in the criminal justice system. We will utilize real-world data to validate a budget
impact tool for MOUD programs in prisons and jails and self-reported healthcare utilization for recently
released MOUD program participants. We will use data primarily based on our experiences in RI for the past
five years, but this research has broad applicability beyond RI and JCOIN. Our first aim is to validate a budget
impact tool developed with national metrics using observed cost values from five years of a comprehensive
MOUD program in a statewide prison and jail system, as well as to test the tool with naïve users to obtain
feedback for tool improvement and adaptation for a community provider end user. Our second aim is to assess
the validity of self-reported healthcare utilization using billing claims among justice-involved clients on
probation/parole with OUD, identify and quantify systematic discrepancies, and develop and validate a
predictive model to adjust and improve self-reported utilization in this population. Although we will utilize real-
world data primarily based on our experiences in RI for the past five years, this research has broad applicability
beyond RI and JCOIN. This research is significant and highly innovative because justice-involved individuals
account for the majority of persons who use drugs in the US and the leading cause of death among former
prisoners is opioid overdose. The challenge of MOUD in corrections is one of implementation and our
proposed research will provide needed critical pragmatic resources. This research will leverage the resources
of our parent JCOIN award, while simultaneously expanding and enhancing our investigative team by the
addition of Weill Medical College faculty with cutting edge expertise in health economics and an exceptional
junior faculty member with expertise in cost modeling and health.

Public health relevance
PROJECT SUMMARY In the proposed project, we will use real-world data to validate a budget tool for MOUD programs in prisons and jails, and self-reported healthcare utilization for MOUD program participants.